Psychosocial, Immunological and Biobehavioral Benefits of Stress Management Interventions for Chronic Diseases: Comprehensive Systematic Review and Meta-Analyses

DESCRIPTION (provided by applicant): Chronic diseases, such as coronary heart disease [CHD], cancer [CA], diabetes [DM], and HIV, are the leading cause of premature morbidity and mortality in the U. S. The course of all chronic diseases is affected by disease-related and life stress. Stress often leads to anxiety and depression, disturbs neuroendocrine and immune function, triggers unhealthy behaviors, and undermines adherence to medical recommendations. To alleviate the harmful effects of stress, behavioral interventions have been developed for people living with a chronic disease. Primary-level research indicates that behavioral interventions can reduce anxiety and depression but such research often has not had the statistical power needed to inform us about alternative outcomes (e.g., treatment adherence, health behavior change), mediating mechanisms (e.g., neuroendocrine and immunological markers), and moderators of intervention efficacy (e.g., patient or disease characteristics). With the recent surge in published research on complementary and behavioral medicine approaches, the literature is now large enough to permit an integrated meta-analytic investigation, which can have more statistical power. Therefore, the proposed research will use meta-analytic methods to gauge the efficacy of stress management interventions to improve hypothesized biomarkers, treatment adherence, health behaviors, and disease progression - as well as psychological outcomes. We will sample research conducted with people living with four prevalent and costly conditions (CHD, CA, DM, and HIV). The proposed meta-analytic research will further our understanding of the efficacy of behavioral stress management interventions in the context of chronic disease, and help to guide future research toward important unanswered questions. The proposed meta-analytic research will also yield results that will be useful to health care providers, insurers, and policy makers who need precise information to make empirically-derived decisions about the optimal content and duration of an intervention, who is most likely to benefit, and how results may vary across chronic illnesses. Innovative aspects of the proposed research from this well- qualified and highly experienced team include (a) use of state-of-the science meta-analytic methods to integrate a large and complex literature, (b) precise measurement of the psychological, neuroendocrine, and immunological benefits accruing from behavioral stress management interventions, (c) identification of mediators and moderators of intervention efficacy, and (d) comparison of benefit across four prevalent chronic diseases. The research is highly significant because of the prevalence, impact, and cost of the four chronic illnesses, the ubiquity of stress, and the need for effective stress management interventions for multiple chronic conditions. The long-term goal of this research is to guide the development of more powerful, efficient, and cost-effective stress management interventions for people living with a chronic disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: These meta-analyses will determine the extent to which stress management interventions improve coping processes, promote better disease management, and reduce morbidity and mortality when used with patients who are living with cardiovascular disease, cancer, diabetes, or HIV. The research will also determine how to optimize the content of these interventions, identify who does and does not benefit, and investigate the mechanisms by which stress management interventions work. The findings from these meta-analyses will be an essential tool to guide practitioners in the implementation of effective prevention programs.